Administrative Core

CORE A: SUMMARY/ABSTRACT
The Administration Core (AC) will provide the leadership and support needed to realize the Center’s overall
goals of addressing complex challenges related to Superfund contaminants including: characterizing mixed
and early-life exposures and perinatal health effects in disadvantaged communities; understanding interactions
among mixed exposures at hazardous waste sites and in health impact assessment; and, developing novel
methods for in situ remediation and remediation of persistent chemicals. Our goals address all four SRP
mandates and the needs of key stakeholders, including those tasked with advancing California’s Human Right
to Water Law. The Directors and RT Coordinator will work closely with Project and Core Leaders and the
External Advisory Board (EAB), engage in regular bi-directional communication and information exchange with
the Stakeholder Advisory Board (SAB), plan and coordinate Center activities, and generate and share timely
information and tools (e.g., remediation technology, data and analytical tools) with NIEHS SRP and
organizations that can improve public health through regulatory and policy change. In Aim 1, the Directors and
RT Coordinator will hold monthly Center meetings to coordinate overall research progress and to foster, plan,
facilitate, and monitor interdisciplinary research and activities across our Center, and between Centers. They
will also hold smaller focused meetings such as weekly ToxicTeam meetings focused on data science and
sharing. They will review progress with the EAB at an annual meeting and interim meetings. In Aim 2, the
Directors and RT Coordinator will interact with the SAB such as by convening expert committees and hosting
workshops and seminars to develop and apply the Key Characteristics (KCs) of Hazard Identification and co-
hosting panels at meetings of mutual interest including those organized by stakeholder organizations. In Aim 3,
the Directors and RT Coordinator will support IIRT by identifying and sharing opportunities for interaction and
facilitating related events; by developing plain language summaries and lightning talks with the Trainees; and
by sharing KC, epidemiological, and exposure data to support assessment, with agencies including CalEPA. In
Aim 4, the AC will work with campus offices to license or commercialize technologies and identify pilot sites to
test in situ remediation technologies with Bruce Marvin at Geosyntec. In Aim 5, we will host interactive
workshops and meetings on cross-cutting topics such as characterization of early-life exposures and
interaction of mixtures in health assessment and remediation, using an effective format and presentation-style
that is accessible to diverse stakeholders and community organizations. The Directors and RT Coordinator will
coordinate with RETCC, to ensure a holistic Trainee experience and to facilitate trans- and interdisciplinary
training and research opportunities; with DMAC, to promote and share diverse datasets with stakeholders and
SRP; and with CEC, to engage with community and environmental justice organizations in Center activities.

Public health relevance
CORE A: PROJECT NARRATIVE The Administration Core (AC) will provide leadership and support to address complex challenges related to Superfund contaminants including: characterizing mixed and early-life exposures and perinatal health effects in disadvantaged communities; understanding interactions among mixed exposures at hazardous waste sites and in health impact assessment; and, developing novel methods for in situ remediation and remediation of persistent chemicals. Thus, the AC will ensure program relevance by responding to all four SRP mandates, and the needs of stakeholders—including those tasked with advancing California’s Human Right to Water Law—and the Research Translation Coordinator will provide timely information and tools (remediation technology, data and analytics) to stakeholders, end-users, communities, and organizations. Our proposed infrastructure and strategy will efficiently leverage the diverse expertise and resources of Center investigators, stakeholders and collaborators, to ensure improved public health and environmental protection through regulatory and policy change.